Basement Membrane Homeostasis and Repair

Summary
Funds are requested to replace our widefield epifluorescence microscope with optical
sectioning capability. Our current Zeiss Axioimager M2 with Apotome for optical sectioning is
12 years old, and we were notified by Zeiss this month that they are no longer supporting this
microscope because of its age. Recently software-machine interface issues have rendered the
microscope unreliable, a situation that was remedied by regular assistance of Zeiss software
support. Without Zeiss’s continuing support, we are extremely vulnerable to the next
malfunction and do not know how much longer we will be able to collect data for the parent
grant. All the Aims of the parent R01 rely on the Axioimager M2 for analysis and quantification
of fluorescently tagged basement membrane proteins in optical sections. At present we are
performing the genetic screen described in Aim 2, during which time the microscope is in use
about 8 hours per day. Thus, we are requesting funds to replace our microscope with the
current model equivalent from Zeiss.

Public health relevance
Narrative Our parent grant investigates basement membrane homeostasis and repair in Drosophila, and analyzing basement membrane in vivo requires fluorescence microscopy. We recently learned that our epifluorescence microscope is no longer being supported by Zeiss, and so we cannot be assured that it will continue to be effective at collecting data. We request funds to replace this microscope in order to complete the aims of the parent grant.